An AI-Based Chatbot for Doxycycline as Post-Exposure Prophylaxis Among Men Who Have Sex with Men

Bacterial sexually transmitted infections (STIs)—including syphilis, gonorrhea, and chlamydia—are increasing in the United States, with disproportionately high rates among men who have sex with men (MSM). These infections can lead to serious health complications such as neurological and cardiovascular syphilis, infertility, pelvic inflammatory disease, and increased HIV transmission. Doxycycline, a widely available and safe antibiotic, has shown promise as post-exposure prophylaxis (doxy-PEP) to prevent bacterial STIs. Motivational interviewing (MI) is effective in promoting HIV prevention behaviors, especially when paired with the Transtheoretical Model (TTM) to assess readiness for change and tailor messaging. However, traditional MI requires multiple sessions and is resource-intensive. This pilot study aims to overcome those limitations by developing and testing SAI (STI Prevention AI-Chatbot), an AI-based chatbot powered by the latest ChatGPT model. In Specific Aim 1, SAI will be tailored to assess STI risk and TTM stage, deliver stage-appropriate education, and use MI-based counseling to promote doxy-PEP uptake among MSM. In Specific Aim 2, we will conduct an open pilot trial with 25 adult MSM recruited via social media to evaluate SAI’s accuracy, usability, appropriateness, and user satisfaction, followed by iterative refinement. If successful, this study will demonstrate the feasibility of using AI to scale behavioral interventions for STI prevention and support broader implementation of doxy-PEP strategies among high-risk populations.
Modified Project Title
An AI-Based Chatbot for Doxycycline as Post-Exposure Prophylaxis Among Men Who Have Sex with Men

Public health relevance
Revised Project Narrative This pilot study will develop and evaluate SAI, an AI-based chatbot using motivational interviewing (MI) to promote doxycycline as post-exposure prophylaxis (doxy-PEP) for preventing bacterial STIs among men who have sex with men (MSM). Powered by the latest ChatGPT model, SAI will assess STI risk and readiness to change, deliver tailored education, provide stage-appropriate MI, and support linkage to doxy-PEP care. An iterative process of implementation, feedback, and refinement will optimize SAI for real-world use.